Substance Abuse Epidemiology Training Program (SAETP) at Columbia University

Substance use and substance use disorders (SUD) constitute major public health problems due to their
associated disability, comorbidity and mortality. Addressing these burdens requires cutting-edge public health
research conducted by scientists of the highest caliber. In 2012, the Substance Abuse Epidemiology Training
Program (SAETP) at Columbia University Irving Medical Center (CUIMC) in New York City was established
with the objective of training talented young scientists to become the next generation of leaders in substance
abuse epidemiology. Through competitive applications, SAETP has successfully, attracted a diverse group of
fellows that have been productive and successful during and after training. Completed SAETP fellows have
attained prestigious research positions in academic research settings and many have obtained their own
independent funding. We now propose the next 5-year renewal cycle for SAETP. SAETP exists in a very rich,
stimulating environment, offering unparalleled academic medical center resources. With its specialized training
for substance abuse epidemiology careers, SAETP is unique at CUIMC. Dr. Deborah Hasin and Dr. Silvia
Martins, SAETP MPIs, are internationally recognized substance abuse epidemiologists with extensive
successful mentoring experience. The 24 other SAETP faculty members offer interdisciplinary expertise (e.g.,
epidemiology, psychiatry, psychology, sociomedical sciences, biostatistics, nursing) and have outstanding
records of publishing, funding, collaborations, and mentoring productive and successful trainees. At any given
time in the renewal, SAETP will continue to train 4 pre-doctoral fellows for training periods of 3-5 years each,
and 4 post-doctoral fellows for training periods of 2-3 years each, a number that has worked well in the current
cycle. Fellows will be selected based on their prior accomplishments, commitment to substance abuse
epidemiology careers, and fit with the SAETP program. Recruitment efforts to enroll under-represented minority
trainees have been successful, with 33% of SAETP fellows from such groups to date (50% currently); we will
continue these recruitment efforts. SAETP will provide broad, intensive training in substance abuse
epidemiology and related areas; depth in one or more areas of specialization; cutting-edge methodological
skills, development of conceptual skills, including formulation of key research questions and testable
hypotheses, and the ability to design and conduct high-quality substance abuse epidemiology studies. Fellows
will receive mentoring and participate in many training components, e.g., weekly substance abuse
epidemiology faculty-fellow seminars, research internships, academic courses. Fellows will also receive training
in the Responsible Conduct of Research and Rigor and Reproducibility in Research. SAETP training will enable
fellows to publish papers, hone presentation skills, learn to write fundable grant proposals, and enhance
collaboration and leadership skills. This rigorous, enriched training will prepare a new generation of outstanding
researchers to address the epidemiology of substance use and SUD, which are urgent public health problems.

Public health relevance
Substance use and substance use disorders, which have increasing prevalence in the US, place a huge personal, social and economic burden on society. Addressing this burden requires state-of-the-art epidemiologic research to detect and monitor trends, and to identify malleable risk factors in different populations in order to inform interventions that will reduce the toll of substance abuse on individuals and society. Since its start in 2012, the Substance Abuse Epidemiology Training Program (SAETP) at Columbia University Medical Center has been training productive, successful junior substance abuse epidemiologists; in a renewal cycle, we propose to continue such training, making the public health relevance of this program very strong.